Tissue Engineered Nigrostriatal Pathway for Anatomical Tract Reconstruction in Parkinson's Disease

ABSTRACT
Parkinson’s disease (PD) is a progressive neurodegenerative disease that affects 10 million people worldwide.
Its motor symptoms result from selective degeneration of dopaminergic neurons in the substantia nigra pars
compacta, leading to a loss of their long-projecting axonal inputs to the striatum. Conventional cell therapy
involves implanting dopaminergic neurons into the striatum; however, this strategy disregards the important
systems-level implications of the native neuroanatomy. Pathway reconstruction strategies aim to address this
limitation by replacing both neurons and axonal fibers in a manner that restores the anatomy – and hence
circuit function – of the lost pathway. We have developed a reconstruction strategy whereby tissue-engineered
nigrostriatal pathways (TE-NSPs) are pre-fabricated in vitro featuring a population of human stem cell-derived
dopaminergic neurons and their long-projecting axonal tracts encased within a biocompatible tubular hydrogel.
TE-NSPs may be implanted to directly replace the pathway, supplying both dopaminergic neurons to the nigra
and providing axonal inputs to the striatum, thereby restoring crucial interconnectivity of the basal ganglia. In
this proposal, we will answer a fundamental and neglected question in cell therapy for PD by characterizing
whether pathway reconstruction with the TE-NSPs enables improved restoration of motor function compared to
conventional striatal grafts in a rat model of PD. Our overarching hypothesis is that TE-NSPs will lead to more
robust motor recovery than striatal grafts through a mechanism involving the reestablishment of physiological
innervation and striatal dopamine regulation patterns more closely matching those of native basal ganglia. This
hypothesis will be tested over three Aims: (1) Establish the ability of TE-NSPs to reconstruct basal ganglia
circuitry via axonal-dendritic synaptic integration; (2) Demonstrate real-time efficacy of TE-NSPs in restoring
nigrostriatal functionality; (3) Assess the influence of TE-NSP activity on motor recovery. TE-NSP mechanisms
and efficacy will be compared to hydrogel-encased nigral or striatal grafts, acellular hydrogel implants, as well
as non-implant and non-lesioned animals out to 24 weeks post-implantation. Motor function will be evaluated
with rotational, forelimb asymmetry and adhesive removal tests. Innervation and connectivity patterns will be
assessed with immunohistochemistry and monosynaptic rabies tracing, while ex vivo and in vivo voltammetry
and [18F]F-DOPA positron emission tomography will be used to analyze real-time dopamine release and
uptake in the striatum. We will also employ chemogenetics to silence neural activity in TE-NSPs to test the
effects on motor function. Overall, TE-NSPs address a crucial gap in clinical treatment by providing a means to
directly replace the nigrostriatal pathway, which may yield significant benefits over other methods by providing
properly-regulated dopamine in the striatum as characteristic of integrated basal ganglia circuitry. These
studies will further the long-term goal of advancing TE-NSPs as a Tissue Engineered Medical Product to
mitigate the neuronal-axonal loss underlying the motor symptoms in patients afflicted by PD.

Public health relevance
PROJECT NARRATIVE Tissue-engineered nigrostriatal pathways (TE-NSPs), consisting of aggregates of human stem cell-derived dopaminergic neurons that extend long axon tracts within tubular hydrogels, are fabricated in vitro and implanted to reconstruct the degenerated neurons and axons of the nigrostriatal pathway in Parkinson’s disease (PD) with anatomical and physiological fidelity. We propose to characterize how TE-NSP performance compares with conventional striatal cell implants in a rat model of PD by evaluating the mechanisms of motor recovery based on innervation and connectivity patterns in the basal ganglia, dopamine release and uptake in the striatum, and neural activity in the implants. Successful completion of the proposed studies may advance TE-NSP mediated pathway reconstruction as a viable treatment strategy and set the stage for further pre- clinical and clinical studies towards the future goal of alleviating the circuitry disruptions underlying motor symptoms in patients afflicted by PD.